Early Life Cardiovascular Disease Risk Factors, Epigenetic Age Acceleration, and Alzheimer's Disease Related Brain Health

ABSTRACT
Dementia is a major global health challenge, and Alzheimer’s disease (AD) comprises 70% of dementia cases.
Because AD has no effective treatment options, the Lancet Commission recently emphasized the critical need
for effective, life-course prevention of AD. Epigenetic age acceleration (EAA), or increased DNA methylation
(DNAm)-based age relative to chronological age, was identified as a powerful biomarker of AD-related
neurobiological substrates and cognitive function in older adults. Likewise, our preliminary data
demonstrated associations between EAA and cognitive function in midlife, a critical epoch in brain health when
subclinical pathology first emerges, and dementia prevention may be most effective. Works by us and others
have also identified associations between cardiovascular disease (CVD) risk factors and EAA, suggesting
that EAA could help to explain the intricate link between early life heart and midlife brain health. Despite these
intriguing data, prospective associations between childhood CVD risk factors and EAA in adulthood remain
unknown and temporal associations are not established. In addition, there is a paucity of research examining
the relationships of EAA with midlife cognitive function decline and AD-related neurobiological substrates. We
hypothesize that EAA is associated with cognitive decline and neurobiological substrates in midlife and
mediates the associations of early life CVD risk factors with these midlife brain health endpoints. To test this
hypothesis, we will leverage the rich resources of the Bogalusa Heart Study (BHS), including life-long
measures of CVD risk factors, three repeated measures of genome-wide DNAm in adulthood, and two midlife
measures of cognitive function over 11-years follow-up in the full cohort of 1,298 BHS participants (850 whites
and 448 African Americans). Furthermore, midlife AD-related neurobiological substrates from 3T magnetic
resonance imaging (MRI) and amyloid photon emission tomography (PET) scans are also available in a
random subsample of 350 BHS participants. As part of the on-going visit cycle (2020-2024), we propose MRI
in another random subsample of 350 BHS participants, amyloid PET scans in another random subsample of
50 participants, along with an additional genome-wide DNAm measure in the full BHS cohort. With these data,
we will assess prospective and temporal associations of early life CVD risk factors with EAA (Aim 1); examine
the associations of EAA with 11-year changes in cognitive function (Aim 2) and neurobiological substrates in
midlife (Aim 3); and analyze the mediating effects of EAA on associations of childhood CVD risk factors with
midlife brain health endpoints (Aim 4). The molecular characterization of midlife brain health may have broad
implications, ranging from the improvement of risk stratification and sub-phenotyping efforts to the pinpointing
of molecular targets for drug development. Identifying CVD risk factor precursors to EAA might suggest optimal
strategies to prevent EAA and its brain-related sequelae.

Public health relevance
PROJECT NARRATIVE The proposed work aims to elucidate the complex relationships between early life cardiovascular disease risk factors, epigenetic age acceleration, and midlife brain health. Knowledge gained from this study may contribute important insights into the biological pathways linking heart and brain health and provide novel strategies for the targeted prevention of epigenetic age acceleration and its brain health sequelae.